CE19-001, Injury Control Research Center (ICRC)

Overall Injury Control Center Application
Project Summary/Abstract
The mission of the Center for Injury Research and Policy (CIRP) is the prevention and control of fatal and
nonfatal injury (unintentional and intentional) and related disability among children and adolescents. With
innovative research as its core, CIRP works to continually improve the scientific understanding of the
epidemiology, biomechanics, prevention, acute treatment and rehabilitation of injuries. CIRP serves as a
pioneer by translating cutting edge injury research into education, policy, programs, and advances in clinical
care. CIRP’s structure and culture foster integrated interdisciplinary collaboration among its world-class team
of research scientists, staff, and partners, including government agencies, non-governmental organizations,
public and private sector entities, community groups, professionals, parents, and other stakeholders. CIRP is
widely recognized as an effective voice and change agent for pediatric injury prevention and control, and plays
a critical role as a resource at local to global levels for translation of injury research into practice. CIRP's
administrative core provides leadership, oversight and support through effective communication, fostering a
positive culture of collaborative productivity, professional development of faculty and staff, and effective
monitoring, evaluation and quality improvement feedback for center activities. CIRP's outreach core facilitates
translation of research into practice through collaborative partnerships; leadership in technical assistance,
consultation, and advocacy; and development, dissemination, and promotion of use of high quality, evidenced-
based, pediatric injury prevention information and resources. CIRP's training and education core provides
training and education opportunities to students at undergraduate, graduate and post-graduate levels to
prepare the next generation of injury prevention professionals, and to public health and other professionals to
promote an interdisciplinary approach to this public health problem at local to global levels. CIRP's research
core facilitates high-quality research, which will fill important gaps in our knowledge and lead to the prevention
and control of pediatric injuries through translation into effective education, policies, programs, and other
interventions.

Public health relevance
Project Narrative Overall Injury Control Center Application Prevention of injuries among children and adolescents deserves special focus and attention, because injuries are the leading cause of death and acquired disability among our nation's youth, and because children have unique anatomic, physiologic, psychological, and other developmental characteristics and needs that require different strategies and interventions for effective injury prevention and control, when compared with adults. Project #1: A Hybrid Effectiveness-Implementation Trial to Improve Safe Driving among Teen Drivers with Traffic Violations PI: Jingzhen (Ginger) Yang, PhD, MPH Teen drivers who have committed a traffic violation are at an increased risk for motor vehicle collisions (MVCs) and related injuries as compared to other drivers. Although parent-focused interventions are effective in improving teens’ driving practices and reducing MVCs, these interventions have not been translated and implemented among high-risk teen drivers, such as those with a traffic violation. Therefore, it is important to use cutting-edge technology to deliver and test an evidence-based parent-focused intervention among high- risk teen drivers in community-based settings, like the traffic court, to improve their safe driving practices and subsequently, reduce MVC-related injuries and deaths. Project #2: Opioid Overdoses and Child Abuse and Neglect Co-PIs: - Bridget J. Freisthler, PhD, MSW and Nichole L. Hodges, PhD The short term goal of the study is to develop a greater understanding of the environmental and social mechanisms that support or hinder maltreating behaviors by parents, particularly as they relate to opioid overdoses. Findings for this project can be used to develop primary prevention activities aimed at populations of families living in neighborhoods with characteristics deemed high risk for potential abuse and neglect. Interventions that change neighborhood conditions may have a greater probability of creating and sustaining safer environments for children. Project #3: Behind the Wheel Smartphone Application: Utilizing Technology to Quantify Driving Behaviors and Promote Safe Driving in Adolescents PI: Motao Zhu, MD, MS, PhD Motor vehicle injury is one of six research priorities outlined by the CDC Injury Center, and adolescents are considered a priority population for motor vehicle-related injuries by the CDC. This study will establish the foundation for a future randomized clinical trial to more definitively test the efficacy of phone apps to improve supervised driving, and reduce high-risk driving behaviors and crashes in adolescents. The contribution is significant, because it utilizes a smartphone app (a ubiquitous technology in our society) that can be easily incorporated into the supervised driving process and widely disseminated to families with varying levels of socioeconomic resources. Project #4: TAILOR: Targeting Adolescent Insomnia to Lessen Overall Risk of Suicidal Behavior Co-PIs: Jeffrey A. Bridge, PhD and Jack H. Stevens, PhD A history of suicide attempt is the single strongest predictor of youth suicide, a major public health concern in the U.S. Primary prevention strategies that aim to prevent a suicide attempt from ever occurring are needed to prevent suicide in young people. The proposed research will be the first rigorous test of a sleep-focused intervention to reduce suicidal ideation in adolescents with recent insomnia and suicidal ideation but no history of attempted suicide.